Multinuclear MRI to Assess Joint Homeostasis after Knee Injury

Project Summary
Post-traumatic osteoarthritis (PTOA) is a common complication that follows an episode anterior cruciate ligament
(ACL) rupture. In the United States, there are over 100,000 ACL ruptures per year, 70% of which occur in
physically active subjects under 40 years of age. The prevalence of PTOA is estimated to be in the 50-70% range
10 to 20 years after injury, whether surgical intervention was performed or not. The failure of surgery to prevent
PTOA leads to the hypothesis that the acute biological and biomechanical changes in the joint directly following
injury trigger a cascade of events leading to PTOA. However, little is known about how these early biological and
biomechanical changes are linked to the subsequent joint damage. To assess the loss of joint homeostasis after
injury, we propose to optimize and use a novel multinuclear magnetic resonance imaging (MRI) method recently
developed by our team, which is based on the simultaneous acquisition of proton (1H) and sodium (23Na) MR
ﬁngerprinting (MRF). Simultaneous 1H/23Na MRF will allow us to characterize knee cartilage integrity using
both proton (structural information from relaxation times, water content) and sodium (proteoglycan content from
sodium concentration and relaxation times) quantitative data. In this study, a complete panel of soluble synovial
ﬂuid (SF) biological markers of inﬂammation and proteolysis, of biomechanical markers (weight-bearing activities,
extensor strength), and of quantitative imaging markers such as 1H/23Na MRF, diffusion tensor imaging (DTI),
contrast-enhanced (CE) MRI, and T1rho MRI, will be acquired longitudinally on patients with ACL injury. The goal
of this study is therefore to develop a predictive model of progression to PTOA using a combination of all these
imaging, biological, and biomechanical markers acquired just after ACL injury, and over time after joint repair. This
prognostic combination of biomarkers will help identify therapeutic targets and monitor the efﬁcacy of intervention
in the development of preventive treatments of PTOA. Two patient cohorts will be recruited: a short-term cohort
will be tested at baseline (post-injury), 1-2-year and 3-5-year follow-ups, and a long-term cohort, which is already
being being studied in our institution with clinical MRI and SF biomarkers, will be tested at 3-5-year and 6-8-year
post-injury follow-ups. In aim 1, we will optimize simultaneous 1H/23Na MRF sequence for its application to knee
cartilage imaging. In Aim 2, we will identify imaging, biomechanical and imaging markers, measured at baseline
and 1.5 years to predict 3-year progression. In Aim 3, we will identify a set of few biomarkers for prediction of
both short-term (3-5 years) and long-term (6-8 years) changes in joint homeostasis.

Public health relevance
Project Narrative Post-traumatic osteoarthritis (PTOA) is a common occurrence after anterior cruciate ligament (ACL) rupture in- dependently of patient treatment, which indicates that early cellular and molecular changes directly after injury seem to be critical in disease development. The goal of this study is to develop a predictive model of progression to PTOA using a combination of multinuclear magnetic resonance imaging markers, soluble synovial ﬂuid biolog- ical markers, and biomechanical markers acquired on patients just after ACL injury, and at different time points after joint repair. This prognostic combination of biomarkers will help identify therapeutic targets and monitor the efﬁcacy of intervention in the development of preventive treatments of PTOA.